Tie2-driven vascular control in critical illness

PROJECT SUMMARY FOR PARENT AWARD R35-HL139424
Sepsis affects millions of Americans annually and is a leading cause for intensive care utilization. Currently no
therapies exist to target the abnormal host response that is widely acknowledged to contribute to multi-organ
dysfunction and death from severe infection. The applicant has received continuous R01 support from the NHLBI
since 2007-2008 to research the host vascular response in sepsis. Our group has identified the Tie2 receptor
and its ligands, the Angiopoietins, as an important switch in the endothelium that may govern essential elements
of the vascular response to sepsis. We have proposed that Angiopoietin-2, an antagonist of Tie2 that is induced
during sepsis, potentiates vascular leakage and thereby contributes to acute respiratory distress arising from
sepsis and related conditions. Since Angiopoietin-2 can be measured peripherally, we have also proposed that
its circulating concentration may predict the risk of adverse outcomes from sepsis and may enable clinicians to
track the host vascular response in a quantitative and operator-independent fashion. Finally, we have recently
found evidence that polymorphisms at the TIE2 locus itself may inform the level of gene expression, and in turn,
how well or poorly an individual’s blood vessels respond to the stress of sepsis. This body of work to which we
and many others have now contributed suggests that we are on the cusp of developing breakthrough
personalized medicine approaches based on the host vascular response in sepsis. Such advances could
revolutionize the care delivered in our ICUs.
This application seeks to develop the core hypothesis that the Tie2 axis may be a crucial determinant of the host
vascular response in sepsis through the following three themes: (1) create humanized mouse models of the Tie2
axis using cutting-edge genome engineering to model the human host vascular response, and its genetic
determinants, in a physiological context; (2) identify major mechanisms by which Tie2 and the endothelium
regulate hemostasis in sepsis; and (3) study the crosstalk between the microcirculation and metabolically active
organs to understand how the host vascular response and dysmetabolism collaborate to drive multi-organ
dysfunction.

Public health relevance
PROJECT NARRATIVE FROM PARENT AWARD R35-HL139424 Acute kidney injury is a common illness among hospitalized patients throughout the world. No drugs or other treatments exist to prevent or improve the course of this illness, and its consequences can be severe. This grant application proposes studies to examine how knowledge about energy metabolism might be applied in the future to treat acute kidney injury.